ENZYMATIC BASIS OF DETOXIFICATION

Two isoenzymes of amine N-methyltransferase from rabbit liver are available in homogeneous form and have been characterized. The enzymes have overlapping specificity for the transfer of a methyl group from S-adenosyl-L-methionine to any one of a very large number of amine acceptors. Acceptor molecules include those of very different carbon skeleton among which are aliphatic, aromatic and heterocyclic compounds that are primary, secondary and tertiary amines. Methylation of the tertiary amines, pyridine for example, results in the formation of a pyridinium ion. It has now become possible to evaluate the role of methylation in the formation of certain hepatocarcinogenic amines. Hepatocarcinogenicity for compounds such as benzidine, N- methylazobenzene and some other aminobiphenyls is well established. Based on work with purified enzymes, N-methyltransferase and a microsomal flavincontaining monooxygenase, it was concluded that carcinogenicity of such aromatic amines required methylation followed by N-oxidation of the resultant N-methyl derivative; the cytochrome P-450 system did not appear to be involved. Thus ben and 4-aminobiphenyl are both methylated and carcinogenic. 4- Aminoazobenzene is neither methylated nor carcinogenic, although the methylated species, 4-methylaminoazobenzene is carcinogenic. All three carcinogenic monomethyl arylamines yield N-oxidized products with the flavin oxygenase. 2-Aminobiphenyl is neither a substrate for the transferase nor does it act as a tumor inducer. It would appear that N-methylation, followed by oxidation with the flavoprotein system, is a means for producing carcinogenic derivatives of the aminobiphenyls.